In vivo role of the fibroblast in muscular dystrophy-Renewal

Abstract
Congenital muscular dystrophies (CMDs) are a group of genetic disorders that lead to neuromuscular
degeneration and profound muscle wasting with early morbidity and mortality, often in adolescence. The more
common mutations leading to CMD are in the LAMA2 gene, although mutations in the 3 genes encoding collagen
VI (COL6A1, COL6A2 and COL6A3) is next most common where it leads to Ullrich and Bethlam myopathy.
While these CMDs have been studied at the molecular levels for over 3 decades now, the field still lacks an
appropriate therapy to treat afflicted individuals. The field also lacks a complete understanding of how this
disease is initiated and propagated, although the overarching mechanism appears to be associated with how
the skeletal muscle myofiber attaches to the overriding basement membrane. Here we will attempt to elucidate
the greater underlying molecular and cellular mechanisms of Ullrich CMD by using a mouse model of Col6a2
deficiency. We hypothesize that detachment of the myofiber from its basement membrane due to collagen VI
deficiency is sensed by integrin complexes where it also leads to TGFβ activation, leading to skeletal muscle
fibroblast (FAP) activation and continued defective ECM generation that generates a reinforcing disease circuit
that furthers the disconnection of the myofiber from the overriding basement membrane and ECM. To dive deeply
into the molecular mechanisms of Ullrich CMD we propose 3 specific aims: Aim #1, to genetically
increase/decrease myofibroblast activity in skeletal muscle of Ullrich CMD mice. Aim #2, to examine if loss of
collagen VI leads to altered myofiber - ECM coupling in Ullrich CMD. Aim #3, to examine TGFβ as a mediator
of myofibroblast-ECM-dependent disease in Ulrich CMD. A strength of this application is the use of genetically
modified mouse models to directly assess the effects of the myofibroblast, TGFβ and myofiber-basement
membrane detachment as primary disease initiating components of CMD in vivo, together generating a 3-way
reinforcing feedback circuit. Finally, this work will suggest obvious translational approaches with gene therapy
or biologics for treating Ullrich CMD (and related CMDs) based on the most proximal disease initiating
mechanisms. For example, Aim #1 would suggest the use of reprogrammed CAR T-cells against activated
fibroblasts, which was recently shown to antagonize fibrotic heart disease. Aim #2 would suggest gene therapy
with a version of the Thbs4 cDNA that broadly upregulates integrins and the DGC to strengthen myofiber
connectivity to the basement membrane broadly. Aim #3 would suggest the use of a selective TGFβ1
antagonizing monoclonal antibody (mAb) in patients.

Public health relevance
Relevance (narrative) The relevance of this application is rooted in the fundamental translational biology of how we might directly treat and address Ullrich CMD in patients. We propose a series of experiments in Col6a2-/- mice that if successful will directly suggest future treatment approaches in afflicted individuals. We are also hopeful that the proposed course of investigation will suggest treatment strategies that could be in common with all the CMDs.